Data Management and Analysis Core

ABSTRACT: DATA MANAGEMENT AND ANALYTIC CORE (DMAC)
In our proposed ACE, we propose a multi-modal, cross-species program which encompasses four synergistic
projects aimed at characterizing the role of sleep fragmentation and sleep physiology on the core symptoms,
repetitive behaviors and cognitive function in Autism Spectrum Disorder (ASD). Leveraging comparative
biology across humans with ASD and complementary genetic animal models of ASD, the overall aims of our
ACE are to examine if multisystem sleep measurements across species a) converge on a common phenotype
of sleep fragmentation and architecture in ASD; b) are differentially associated with the core, behavioral and
cognitive symptoms of ASD; and c) if sleep normalization in humans with ASD and animal models of ASD,
alleviate the core, behavioral and cognitive symptoms of ASD. The management and analysis of such large,
multi-domain, comparative data sets include careful maintenance and tracking of the quality and eventual
sources of heterogeneity, correct calibration and quality control of the data and control for the multiplicity of
choices in the normalization and metrics. The DMAC will employ a reproducible approach to the development
of the complete statistical analyses and record to attain the following objectives.
Objective 1: Coordination, transfer, integration and management of data across all ACE Projects, and their
different platforms; Objective 2: Integration, calibration and normalization of data sets from the different
sources; Objective 3: Design, Analysis, and Power Estimation; and Objective 4: Integrating and analyzing
comparative data across the RAC and Projects 1-4.